The role of wake-associated protein kinase A transients in intrinsic plasticity and learning through aging

Project Summary:
Cognitive deficits including disruptions in hippocampal-dependent memory are a hallmark of aging. Predictably,
aging-associated cognitive decline is exacerbated by sleep disruptions commonly seen in the aging and elderly
population. However, there is a significant lack of understanding about the mechanism behind the
interconnected processes of sleep, aging and learning. One significant challenge to unraveling these
mechanisms has been the lack of tools to study intracellular and extracellular signals in real time with high
temporal resolution. This has made it difficult to observe the modulation of these signals alongside such
dynamic processes as sleep, learning and aging. To address these challenges, our lab developed a
fluorescence-lifetime based optical sensor, FLIM-AKAR, which when used in combination with a custom-built
fluorescence lifetime photometry (FLiP) rig has allowed us to observe the activity of cAMP-dependent protein
kinase A (PKA), an important plasticity signal that has been implicated in the formation and consolidation of
sleep-dependent learning and has been shown to enhance learning in aging mice. Paring 24-hour FLiP
recordings in hippocampal CA1 with simultaneous electroencephalography (EEG) and electromyography
(EMG) measurements revealed a synchronized, transient activation of PKA that is associated with transitions
from sleep to wake. Due to its short duration, this signal has never been observed before in a behaving animal.
Thus, this study aims to explore its function on both cellular and behavioral levels and elucidate how those
functions may change in aging mice. Using photoactivatable adenylate cyclase (biPAC) and perforated patch
clamp, I will determine whether transient PKA activation is sufficient to cause an increase in intrinsic excitability
(IE), a known function of PKA and a known cellular correlate of learning. Further, by using biPAC and
photoactivatable protein kinase inhibitor peptide (PA-PKI) to bidirectionally manipulate this transient PKA
signal, I aim to determine whether increasing the frequency of these transients can rescue hippocampal-
dependent learning deficits in aging mice or disrupt intact hippocampal-dependent learning in adult mice.
Ultimately, our findings will provide a more nuanced understanding of how PKA functions at physiologic
timescales and in the context of aging, sleep, and learning. This study will also stand as an example of how
taking advantage of new optical tools can bolster our understanding of how the dynamics of cell signaling
relate to complex behaviors.

Public health relevance
Project Narrative: Aging-related cognitive decline is a significant concern amongst the elderly, and disruptions in memory can drastically reduce independence and quality of life. This study aims to further our understanding of the mechanisms that underlie learning by studying the dynamics of plasticity signals and how those might change in the context of aging. This knowledge could then inform the development new therapies for improving memory deficits, which has the potential to significantly improve the quality of life for a large portion of the aging population.